Neural and Behavioral Correlates of Live Face-to-Face Interactions

Summary
Recent interest in the neural correlates of naturalistic behaviors has increased the need for tools to acquire
multimodal measures during real world contexts. Human faces in natural settings are primary sources of socially
communicated information but are traditionally studied in non-interactive contexts. Faces not only carry the
structural information that serves identification, but also communicate social cues driven by live and spontaneous
dynamics that convey emotion, direct attention, and regulate eye-to-eye contact. However, this domain of live
and natural interacting faces has not been widely studied due to the absence of reliable and validated
measurement methods appropriate for observing such interaction under ecologically valid conditions. We
address this knowledge gap here by proposing to establish a Social Interaction Suite (SIS) of synchronized
neural and behavioral tools designed for measurements of cognitive networks associated with processing facial
cues and their correlated behaviors exchanged in live social interactions. SIS is developed on a neural imaging
platform based on functional near infrared spectroscopy (fNIRS), a head mounted optical imaging system, to
acquire hemodynamic signals that originate from superficial cortex. This suite of tools will include simultaneous
and synchronized electroencephalography (EEG), eye-tracking, pupillometry, facial feature tracking and
associated emotive categorization, subjective responses (dial ratings), and physiological monitoring during live
eye-to-eye contact and emotional contagion tasks. Prior studies of dyadic face interactions provide evidence that
real faces engage specialized neural circuits beyond the well-known ventral stream face processing circuits and
include right superior temporal gyrus (rSTG), supramarginal gyrus (rSMG) and angular gyrus (rAG). Eye-to-eye
contact additionally engages regions in the dorsal parietal area, right somatosensory cortex (rSSAC). We aim
to advance a theoretical framework for this interactive face and eye-contact model by testing the hypothesis that
the live-face and the eye-to-eye contact systems are dissociable cortical pathways. Validation and
characterization of the model will be performed by continuous transcranial brain stimulation (cTBS) to disrupt
candidate regions in the live face processing systems at sites informed by the previous pilot fNIRS and behavioral
data. Following the completion of the initial tool development and validation phase, the obtained results will be
used in the application of functionally defined multi-electrode targeted transcranial direct current stimulation
(tDCS) to test hypotheses related to up and down regulation of the dorsal parietal and lateral face processing
regions. Successful manipulation of eye contact under excitatory and inhibitory tDCS stimulation of the dorsal
region will extend our cTBS results and provide proof of concept for the application of neural modulation as a
tool for facilitating social interaction.

Public health relevance
Narrative Although the interpretation and reciprocal sending and receiving of live face cues between dyads is a central feature of typical human social behavior and difficult for many individuals with psychosocial conditions, the underlying neural correlates remain largely unexplored due to the absence of measurement tools suitable for live and natural situations. An objective of this proposal is to construct a novel tool, referred to as the Social Interaction Suite (SIS), for synchronized neural and behavioral measurements of dyads during live face-to-face and eye to eye interactions. With this new tool, SIS, we aim to validate neural and behavioral measures of live face and eye contact, and in phase 2 apply neuromodulation to the identified neurocircuits during live face processing and eye-to=eye contact to refine understanding of the neural and behavioral correlates that underlie mechanisms of the human social brain and to establish a foundation for beneficial intervention.